CWRU-Visual Sciences Training Program

The Visual Sciences Training Program (VSTP) at Case Western Reserve University (CWRU)
offers multidisciplinary training in fundamental and translational vision science. This training
program advances research in the following thematic areas: (a) Retinal Development and
Function; (b) Retinal Disorders: Diabetic Retinopathy (DR) and Age-related Macular
Degeneration (AMD); (c) Biochemistry, Cell Biology, Immunology of Eye Diseases; and (d)
Genetics, Physiology, and Epidemiology of Eye Diseases. An essential objective is to provide an
efficient and vibrant collaborative training environment which integrates basic science with
translational and clinical research. Therefore, the VSTP partners with the Core Modules of the
Visual Sciences Research Center, University Hospitals Cleveland Medical Center (UHCMC), the
Cleveland Clinic Lerner College of Medicine and Cole Eye Institutes (CCLCM), and the Louis
Stokes Cleveland VA Medical Research Center. Our interdisciplinary program is built upon and
supported by basic and clinical scientists in the Departments of Population and Quantitative
Health Sciences, Medicine, Molecular Biology & Microbiology, Ophthalmology & Visual Sciences,
Pathology, Pharmacology, Physiology & Biophysics, and Systems Biology & Bioinformatics
(CWRU and UHCMC) and Ophthalmology (CCLCM). Our established faculty members work in
conjunction with our junior faculty to cultivate a robust mentoring environment and to promote
innovative projects in vision science. The 29 faculty of the T32 Institutional Training Grant
application seek renewed support for four predoctoral student positions and one postdoctoral
position in all years. The goal of the program is to develop professional scientists with the maturity
to address novel research questions in vision sciences through innovation and collaboration.
Rapid advances in biotechnology and bioengineering coupled to the ever-expanding development
of new therapeutics for eye diseases has created a growing need for highly qualified scientists
with core training in the principles and practice of visual sciences. Our multifaceted approach
incorporates not only basic science, translational research, and didactic coursework but also
enrichment opportunities such as the Annual Association for Research in Vision and
Ophthalmology Conference, Vision Research Seminar Series, the Vision Science Data
Conference, and the Annual VSRC Symposium. These educational experiences will equip
trainees with a strong foundation and technical skills to make them competitive candidates for
careers in academia, industry, and healthcare.

Public health relevance
PROJECT NARRATIVE Twenty-nine faculty affiliated with the Visual Sciences Research Center (VSRC) at Case Western Reserve Uni- versity (CWRU) seek renewed support for the Visual Sciences Training Program (VSTP). This T32 Institutional Training Grant renewal application is organized according to a Visual Sciences Community representing four major vision science research themes: (a) Retinal Development and Function; (b) Retinal Disorders: Diabetic Retinopathy (DR) and Age-related Macular Degeneration (AMD); (c) Biochemistry, Cell Biology, Immunology of Eye Diseases; and (d) Genetics, Physiology, and Epidemiology of Eye Diseases. Continued support is re- quested for four predoctoral positions and one postdoctoral position in all years.